Project 2: Translating Cardiac Xenotransplantation

ABSTRACT
To earn the confidence of the scientific community, regulatory authorities, and, ultimately, our patients that
cardiac xenotransplantation deserves to be systematically evaluated in humans, it is essential to demonstrate
consistent long-term, life-supporting heart xenograft survival in a preclinical model. This imperative is
underscored by the occurrence of graft failure, apparently immunologically mediated, in Maryland’s two initial
clinical heart xenotransplant cases. Preclinical data from the Maryland and Munich teams and our recent report
demonstrate that, while the previously intractable barrier of delayed xenograft rejection (DXR) can sometimes
be overcome, consistent long-term survival of genetically engineered (GE) heart xenografts in nonhuman primate
(NHP) recipients has not yet been achieved. We propose to evaluate three likely explanations. First, emerging
evidence suggests that knocking out the cytidine monophosphate-N-acetylneuraminic acid hydroxylase (CMAH)
gene probably accounts for the shortened survival of triple-knockout (TKO) hearts in NHPs (but would be
irrelevant in humans). Second, mechanistic studies from NHP and human recipients of pig hearts (and kidneys)
strongly suggest an important role for NK cells in xenograft injury. Finally, immunosuppressive strategies for
heart xenotransplantation need to be further refined in clinically relevant preclinical models to promote safe long-
term recipient survival with minimal toxicity and infectious risks. To test these hypotheses, we propose to 1)
evaluate the contribution of the CMAH gene KO to pathogenic immune injury occurring in 10-GE TKO heart
xenografts, 2) downregulate host NK cell activity by expressing HLA-E in 9- or 10-GE hearts, and 3) evaluate
the efficacy of αCD28 and dual αCD154/αCD28 costimulation pathway blockade in preventing/mitigating
pathogenic immunity. These studies will be enhanced by Projects 1 and 3, which will test complementary but
nonredundant hypotheses aimed at demonstrating consistent long-term life-supporting survival in NHP recipients and
identify organ-specific differences, if they exist. State-of-the-art mechanistic assays and pathological studies
coordinated by Core B will enable rapid cross-fertilization of insights gained in each project, the microbiological studies
in Core C will provide critical data to ensure the safety of clinical xenotransplantation. Core D will provide the unique
multi-GE pigs that are foundational to this Program. We anticipate that together, these highly interactive, innovative
Projects supported by world-class Cores will generate one or more safe and effective protocols ready for clinical trial
‘translation’ by the end of the funding period. If successful, these studies would impact the entire field of transplantation.

Public health relevance
PROJECT NARRATIVE Many patients with heart failure waiting for a transplant die each day because of the lack of donor hearts. If pig hearts could be used to increase the number of transplants every year, many lives would be saved. These studies will explore ways to achieve successful pig-to-human heart transplantation.